Quorum-sensing mediated communication between pandemic Vibrio cholerae and phage VP882

PROJECT SUMMARY/ABSTRACT
Bacteria are bombarded by infecting viruses, called phages, in natural habitats. Upon infection of a host, phages
must undertake one of two lifestyles: lysogeny where the phage remains in the host and is passed down to
offspring, or lysis where the phage replicates, kills the host, and spreads to new cells. Phages have been thought
to transition from lysogeny to lysis exclusively in response to host stress and DNA damage. New research from
the Bassler laboratory has revealed that phages can monitor host communication molecules, called
autoinducers. In a process called quorum sensing, bacteria produce, release, and detect autoinducers, and in
response, orchestrate group behaviors. Quorum-sensing-responsive phages detect host-produced autoinducers
and exploit the information they garner to drive their lysis-lysogeny lifestyle transitions. These recent findings
position me to discover how phages manipulate bacterial hosts and the consequences to the host, to the multi-
species bacterial community of which the host is a member, and to the eukaryotic host in which all the entities
reside. The overarching goal of my research is to define how cross-domain communication between vibriophage
VP882, the first phage discovered to “eavesdrop” on quorum sensing, and its host, the global pathogen Vibrio
cholerae, launches the phage lytic cycle. Using a combination of genetic, biochemical, and structural
approaches, I will identify the molecular mechanisms underlying this host-phage chemical communication
process. First, I will learn skills in bacterial genetics from experts in the Bassler laboratory and conduct a genetic
screen to identify the repressor of the quorum-sensing-induced phage lytic cycle. Second, I will use biochemical
methods to quantitatively characterize interactions between two key signaling components in the quorum-
sensing-induced phage lysis pathway. Lastly, I will rely on my background in structural biology to solve the
structures of these same signaling components, individually and in complex, enabling atomic-level-resolution
understanding of the interactions required for the phage to undergo lifestyle transitions. The ideal outcomes of
my research are a mechanistic understanding of inter-domain chemical communication and new possibilities for
development of phage therapies. Honing my skills in bacterial genetics, protein biochemistry, and
macromolecular crystallography over the course of my postdoctoral training will enable me to launch an
independent research program at a top-tier research institution.

Public health relevance
PROJECT NARRATIVE Phage VP882 is the first discovered phage capable of detecting bacterial host-produced quorum-sensing communication molecules, called autoinducers. Autoinducer detection by phage VP882 drives its lysogeny to lytic transition, resulting in host lysis. The proposed work will combine genetic, biochemical, and structural approaches to provide a mechanistic understanding of cross-domain communication between vibriophage VP882 and its host, the global pathogen Vibrio cholerae; it will also lay the necessary foundation for engineering phages responsive to particular sensory cues for phage therapy development.